Early Intervention to Promote Cardiovascular Health of Mothers and Children (ENRICH) Multisite Resource and Coordinating Center

Poor cardiovascular health (CVH) contributes to high levels of morbidity and mortality in the United States, with
profound health disparities by race/ethnicity, socioeconomic status, and geography. Sustained improvement in
CVH requires 2-generation strategies in settings where those at elevated risk for poor CVH already receive
care. Evidence-based home visiting (HV) provides an ideal setting to reduce health disparities, reduce
maternal morbidity, and promote CVH in infants and children in ways that can be continued across the life
course. Prior studies of CVH intervention effectiveness have not tested interventions across HV models,
incorporated emerging technologies such as mHealth and telehealth, combined HV with services in other
settings where mothers and children receive care, acknowledged mediators and moderators of effectiveness,
nor used individual and composite maternal and child CVH metrics to assess outcomes. The Early Intervention
to Promote Cardiovascular Health of Mothers and Children (ENRICH) program aims to address these
limitations. It will test a common implementation-ready intervention to promote maternal and child CVH and
reduce CVH disparities in the context of multiple evidence-based HV models. The success of ENRICH requires
a Resource and Coordinating Center (RCC) with sophisticated content and methods expertise and resources
to support study design and implementation of a common intervention and research protocol attuned to
heterogeneity in individual, family, and community context. The Johns Hopkins RCC multidisciplinary team
combines the expertise of the Home Visiting Applied Research Collaborative (HARC), the Johns Hopkins
Center for Clinical Trials and Evidence Synthesis (CCTES) and the Johns Hopkins Center for Health Equity.
This RCC team offers an unparalleled combination of a national HV platform, expertise in health equity, and
clinical trials infrastructure to create new management strategies, organization concepts and impactful
analyses to assure that ENRICH achieves its potential. Our RCC includes: (1) stakeholder-built HV Precision
Paradigm; (2) content expertise and leadership in HV and CVH; (3) state of the art methods to design and
implement a common protocol, analyze data, disseminate results, and translate for policy and practice (4)
advanced methods to assess “What works best, for whom, in which contexts, why and how?” and assess ideal
CVH metrics for both mothers and children; (5) tight linkage with HV and CVH stakeholders; and (6) expertise
in engaging and training Early Stage Investigators and HV staff professionals. The RCC will apply the
strengths of three JHU divisions (Public Health, Medicine and Nursing) to ENRICH to generate impactful
evidence on effectiveness of the ENRICH intervention and powerful data on generalizability to enhance
translation. The RCC will assure that ENRICH achieves its full potential and generates rigorous, innovative,
timely and actionable new knowledge to reduce maternal morbidity, promote CVH and reduce CVH disparities
in mothers and young children.

Public health relevance
NARRATIVE Poor cardiovascular health (CVH) contributes greatly to maternal morbidity and mortality in the United States, and many families enrolled in home visiting are at risk for poor CVH. Improving CVH requires focusing on CVH risk factors, 2-generation strategies addressing mothers and children, and greater use of settings where families already receive care. The Johns Hopkins Early Intervention to Promote Cardiovascular Health of Mothers and Children (ENRICH) Resource and Coordinating Center will generate rigorous, innovative, timely and actionable new knowledge to promote CVH and reduce CVH disparities in mothers and young children.